A Theranostic, Multiparticle, National Cyclotron Resource at UW-Madison

Project Summary / Abstract
The Cyclotron Research Group in the School of Medicine and Public Health (SMPH) Department of Medical
Physics stewards a GE PETtrace 16 MeV proton / 8 MeV deuteron cyclotron in the Wisconsin Institutes for
Research and Discovery whose capacity and capabilities have become insufficient to meet growing demand for
theranostic radionuclides. The group has a four-decade history of achievement in research, training, and
revenue-neutral service provision as an institutional and national resource in radionuclide production. Building
on a successful C06 award in 2023, funding is requested to purchase a 30XP multiparticle cyclotron
manufactured by Ion Beam Applications (IBA) of Louvain la Neuve, Belgium. This machine accelerates
extractable negative ion proton and deuteron beams with maximum beam intensities of 400 and 50 µA,
respectively, and can be configured in positive ion mode to accelerate alpha beams up to 50 µA. The machine
has variable position stripping foil mounts to feed each of two extraction ports, creating the option for nominal
variable energy for the proton (15-30 MeV) and deuteron (8-15 MeV) beams.
The machine will be configured with three primary target end stations, each servedby a combination of switching
magnets and multiple-quadrupole focusing elements. A five-port switching magnet on the first extraction port of
the vacuum tank will send beam to one of five individual targets at a time, enabling rapid switching between
targets for 18F, 11C, a dummy for accelerator developing and beam tuning, and two oblique, coin-type solid target
stations that can each produce a wide range of isotopes (64/67Cu, 89Zr, 52g/51Mn, 86Y, 55Co, 117/119Sb, 45Ti, 43/44/47Sc,
203Pb, 201Tl, and many others) needed by biomedical researchers. The second extraction port’s beam will be split
by a selection magnet in the main vault and directed to an independently-accessed secondary vault with two
high-current (>100 µA) end stations homing glancing incidence solid targets. Each beam line is equipped with
dual quadrupole magnets and beam “wobblers” to distribute the intense thermal power these target stations can
tolerate. Wire scanning and phosphorescent screen beam profile monitors will be equipped on each beamline to
ensure quantitative intercept of the beam’s transverse profile by the desired target material. All target stations
will be equipped with remote transport solutions that feed radiochemical hot cells in adjacent laboratories.
The variable extraction system will also be capable of extracting user-selectable fractions of the beam, thereby
allowing simultaneous beam delivery at a single energy to both extraction ports, dramatically increasing the
flexibility of production scenarios. The combination of infrastructure described will more than quadruple available
quantities of standard positron- and single photon-emitting radionuclides for imaging and make new therapeutic
radionuclides (especially radiometals from solid target irradiations). These materials are needed by over 40
current awards distributed between local UW and national components of the user base and will also support
the education and training mission of the Group and multiple T32 awards.

Public health relevance
Project Narrative Medical imaging and therapy using drug molecules coupled to radioactive atoms is among the most sensitive and powerful technologies available for diagnosing and managing cancer and neurological disorders, and exciting radiopharmaceutical-based technologies to address other conditions like chronic pain and diabetes are being actively explored. The starting materials for these technologies are radionuclides, atoms that decay and emit useful particles, commonly made using particle accelerators called cyclotrons, and demand for them in biomedical research has skyrocketed globally over the last decade. This proposal requests funding to purchase a new cyclotron, the first of its kind in the United States, which will dramatically expand the scope and magnitude of the materials that the University of Wisconsin’s Cyclotron Research Group can provide its national user base.